NOVEL DROSOPHILA TRANSCRIPTION FACTOR ORTHOLOG OF BCL11A/BCL11B IS CRUCIAL FOR REGULATING INTESTINAL STEM CELL QUIESCENCE AND PREVENTING GUT DYSFUNCTION DURING AGING

PROJECT SUMMARY AND ABSTRACT
Stem cells are essential for tissue homeostasis following environmental challenges. During aging however, these
stem cells lose this ability to maintain tissue integrity. Dysregulation in the proliferation and the differentiation of
stem cells are implicated in several pathologies such as cancer, hematological disorders, and gastrointestinal
disease. Intestinal stem cells (ISCs) reside in the digestive tract epithelium and their balance between active and
quiescent states is disrupted during aging. Several signaling pathways that are dysregulated in aging ISCs have
been characterized, however, the mechanism by which ISCs transit between active and quiescent states during
an organism’s lifetime is relatively unknown. Here I propose using Drosophila melanogaster to model the
regulation of quiescent and active states with their Drosophila ISC (dISC) population given the excellent
orthology with mISCs. Drosophila have the advantage of being inexpensive, reproducing rapidly, short-lived, and
having plentiful genetic resources available. There are many datasets available to characterize dISCs and their
changes during aging. These resources include single cell sequencing datasets from young and old fly guts
developed in the lab: the Fly Cell Atlas (2022 Science) and the Aging Fly Cell Atlas (2022 Science). Using a
bioinformatics analysis-guided genetic screen approach I identified an uncharacterized transcription factor
required for proper regulation in dISCs, Chronophage (Cph, “time-eater”). This gene is an ortholog of two
essential genes in humans: BCL11A and BCL11B, which also have specific expression in mISCs from curation
of mammalian scRNA-seq datasets. Preliminary evidence from the screen showed an defect for ISCs to
proliferate and differentiate when Cph was lost. Additionally, this gene’s expression is reduced in aged dISCs,
suggesting a potential role in gut degeneration during aging.
The role of Cph has only been defined in neural stem cells and muscle cell progenitors, showing the critical
function of Cph for proliferation and differentiation in these cell types. Therefore, I hypothesize Cph is required
for the homeostasis and proper regulation of dISCs between active and quiescent states, and is indispensable
for gut maintenance during aging. For aim 1, I will characterize the cellular and molecular mechanism this occurs
by generating a new reporter line and driving cell-specific KD of Cph, characterizing potential regulators of Cph,
and then apply a novel single cell multiome sequencing approach to identify genes that Cph regulates and how
dysfunction impacts the microenvironment. In aim 2, I will study the age-associated decrease of Cph and explore
whether and how its decline contributes to gut degeneration. This work will have significant implications for how
aging impacts ISC function and how stem cells regulate the transition between active and quiescent states.

Public health relevance
PROJECT NARRATIVE Aging causes systematic changes in all cell types and tissues, predisposing organisms to a wide range of diseases. Stem cell function is disrupted upon aging, unable to properly regulate the transition between quiescence and active states, which can result in cancer or tissue degeneration. Using single-cell RNA sequencing data, I have identified a novel regulator of intestinal stem cells called Chronophage, which is required for maintenance of intestinal stem cells and contributes to gut pathologies when dysregulated.